Mechanisms of Cell Communication in Animal Development

The broad objective of my research program is to unravel the fundamental rules and mechanisms governing
cell-cell communication that underlie the formation of complex tissue patterns in animals. The precision with
which cells regulate levels, timing, location, and directionality of long-range signal communication is vital for
animal development. Any deviation from this control mechanism can lead to developmental anomalies and
disease. While conventional models suggest that secreted signaling proteins passively diffuse through the
extracellular space to convey information from cell to cell, my previous research laid the foundation for
understanding a more precise form of extracellular signal dispersion by characterizing a novel asymmetric
'direct delivery' mechanism orchestrated by specialized actin-rich signaling filopodia known as cytonemes.
Cytonemes are thin actin-based membrane protrusions that enable cells to physically interact with each other
and send or receive signals through their contact sites in a polarized manner. To unravel the mechanisms that
control cytonemes and cytoneme-mediated signaling, we focus on a developing tracheal epithelial tube and a
muscle stem cell niche in Drosophila and investigate intercellular communication of Fibroblast Growth Factor
(FGF), an essential signaling protein in metazoan development. We discovered that cytonemes emanating
from these tissues exchange FGF through their contact sites in a highly polarized manner. We found that the
number and directionality of these cytonemes are precisely regulated by the intricate FGF signaling feedback
mechanisms. This self-regulatory feature of FGF signaling allows it to control its own levels and spatial range
by modulating the formation of FGF-receiving cytonemes. These findings also shed light on the self-regulatory
attribute of cytonemes that can shape signaling asymmetry and promote self-organization. Furthermore, we
discovered a series of post-translational enzymatic cleavage and lipid modification of an FGF. Surprisingly,
these modifications prepare FGF for cytoneme-mediated exchange by controlling its intracellular trafficking,
membrane-anchored display, and subsequent release of the membrane-anchored FGF from the cell surface
via an intricate enzymatic shedding mechanism. These discoveries have opened up new avenues of
investigation into the regulatory mechanisms that selectively release lipid-modified signals like FGF through the
cytoneme contact sites and thereby control the location, timing, and levels of signal exchange. Building on
these significant leads and leveraging our expertise in genetics, molecular and cell biology, and high-resolution
imaging, our future research aims to delve deeper into the intricate molecular and cellular mechanisms
governing cytoneme-mediated polarized signaling and self-organization. Given the conservation of the
essential signaling mechanisms and the critical significance of asymmetric signaling across organisms, this
research will have profound implications for both developmental biology and disease research and will offer a
conceptual framework for future tissue engineering.

Public health relevance
To unravel the intricacies of cell communication crucial for animal development, our research focuses on understanding how cells precisely send or receive developmental signals through the extra-cellular space, and how this process guides distant cells to work together to build complex tissue architectures. Leveraging Drosophila as a model system and employing advanced microscopy on live embryos, we provide evidence of a novel process involving cytonemes - dynamic membrane protrusions that cells extend to carry and exchange signals target-specifically through their contact sites. Building on this discovery, our investigation aims to uncover the fundamental rules and mechanisms of this unique and essential cellular communication, and we predict that a comprehensive molecular understanding will not only reveal the secrets of cell communication but also offer profound insights into cell-cell signaling in both normal development and disease processes.